From T Cells to Dendritic Cells: Mechanistic Dissection of CTLA4 and TIM3 in Cancer Immunity

PROJECT SUMMARY
Immunotherapy targeting the immune checkpoint receptors (ICRs) PD1, CTLA4 and Lag3 – molecular
brakes of our immune system - has revolutionized oncology, but it only benefits a small subset of patients. The
limited mechanistic understanding of checkpoint signaling has become a significant barrier to expanding the
clinical benefits of immunotherapy. In addition to the adaptive arm of anti-tumor immunity, particularly T cells
where these receptors are predominantly active, the critical role of understudied innate anti-tumor immunity has
been increasingly recognized. Notably, ICRs such as PD1, VISTA and TIM3 are also expressed in innate immune
cells and play essential roles in anti-tumor immunity. Thus, an in-depth understanding of checkpoint signaling in
both the adaptive and innate immunity will be pivotal for harnessing the full potential of immunotherapy. This
project investigates the mechanism of two central ICRs, CTLA4 and TIM3, in adaptive and innate anti-tumor
immunity respectively, to provide the foundation for novel therapeutic strategies.
During the F99 phase of this project, I will investigate the molecular mechanism of CTLA4 in cytotoxic
CD8+ T cells. CTLA4 research has historically centered on CD4+ T cells, where it maintains peripheral tolerance
by restraining the activity of CD28, a costimulatory receptor known to be triggered by B7 (CD80/CD86) on
antigen-presenting cells (APCs). However, recent studies and my preliminary data (see Progress Report)
highlight the importance of CD8+ T cell-intrinsic CTLA4 in anti-tumor immunity, although the mechanism is
unclear. Notably, CD8+ T cells can also express B7, either endogenously (B7endo) or acquired from APCs via
trogocytosis (B7trogo), to trigger CD28 from the same T cell in cis in APC-sparse peripheral tissues. Based on
these studies and the strong endocytic feature of CTLA4, I hypothesize that CTLA4 in CD8+ T cells act as a cell-
intrinsic “molecular sink” to deplete B7 in cis. In the F99 phase, I will test this hypothesis both in vitro and in
mouse tumor models, with the potential of addressing the long-standing mechanism of CTLA4 in CD8+ T cells.
In the K00 portion, I plan to dissect the molecular mechanism of ICRs in innate immune cells, focusing
on TIM3, another important yet poorly understood ICR. I plan to study TIM3 in dendritic cells (DCs), a type of
myeloid innate immune cells critical for antigen presentation in the cancer immunity cycle. While TIM3 is primarily
known as a marker for T cell terminal exhaustion, its function in T cells remains ambiguous with both stimulatory
and inhibitory roles reported. Recent studies, however, highlight TIM3’s significance in intratumoral DCs in both
human cancer patients and mouse tumor models. These exciting data urge a shift of focus of TIM3 biology from
T cells to myeloid cells. In the K00 phase, I plan to leverage a unique combination of membrane reconstitution,
cellular imaging, CRIPPR-editing, and mouse tumor models to elucidate the biochemical and molecular
mechanism of TIM3 in DCs, including its physiological ligands, downstream effectors and its role in the
development and function of DC subsets in cancers.

Public health relevance
PROJECT NARRATIVE ICR blockade immunotherapies targeting PD1, CTLA4, and Lag3 have revolutionized cancer treatment, yet they benefit only a small subset of patients and often lead to autoimmune toxicities, highlighting the need for better mechanistic understanding of checkpoint signaling pathways. While adaptive immunity, especially T cell responses, has been the primary focus, there is growing recognition of the innate immune system’s role in anti- tumor activity. My F99/K00 projects seek to elucidate how the two pivotal checkpoint receptors, CTLA4 and TIM3, function in adaptive and innate immunity respectively, to advance our mechanistic insights and potentially uncover new strategies for cancer immunotherapy.